Genetic and social network analysis to target interventions for malaria elimination

PROJECT SUMMARY/ABSTRACT
This proposed K01 award will support the career development of Dr. Jennifer Smith, an Assistant Adjunct
Professor in the Department of Epidemiology and Biostatistics at the University of California, San Francisco
(UCSF). Dr. Smith's career goal is to become an independent researcher with combined expertise in parasite
genotyping and human network analyses to optimize interventions for infectious disease elimination. To
support her career development, this application proposes a study that leverages data collected as part of
ongoing research in malaria high-risk populations and uses novel genetic and social network analyses to
address an urgent challenge preventing achievement of malaria elimination targets. As malaria transmission
declines, an increasingly large proportion of the parasite reservoir is clustered in specific sub-populations with
high exposure to infection and who often face significant barriers to accessing and utilizing malaria
interventions. While normative bodies like the World Health Organization recommend a targeted response in
known malaria high-risk populations, there is limited evidence on the extent to which these populations drive
transmission, the impact of targeted interventions or how to optimize coverage. Through cross-sectional and
temporal analysis of genetic and social network data collected as part of an existing, separately funded
population-based evaluation of targeted malaria interventions in high-risk populations, this K01 proposes to
investigate genetic connectivity between infections in migrant and resident populations and the role social
networks play in uptake of malaria interventions. The specific aims are to (1) quantify parasite genetic
connectivity and transmission potential within and between migrant and resident populations at different time
points and spatial scales, (2) evaluate the influence of social network attributes on uptake of malaria prevention
measures, and (3) model transmission networks and estimate the impact of alternative intervention strategies
in migrant and resident agricultural workers. This study will provide crucial knowledge on how malaria high-risk
populations contribute to transmission dynamics, inform how social networks can be leveraged to improve
intervention uptake, and quantify the impact of targeted interventions on overall transmission. The proposed
research will build on Dr. Smith's foundation in epidemiologic methods and include a 5-year training plan
including mentorship from leaders in genetic and malaria epidemiology, social network analysis and
mathematical modelling at UCSF, University of Southern California and UC Berkeley. Dr. Smith's training goals
are to (1) gain knowledge in malaria genetic epidemiology and applied analytic approaches for genetic data, (2)
develop expertise in advanced social network theory and analytic methods, and (3) obtain training in
mathematical modelling. The findings will be used as a foundation for an R01 to implement and evaluate
network-based interventions among malaria high-risk populations in northern Namibia.

Public health relevance
PROJECT NARRATIVE While traditional epidemiological approaches have resulted in significant reductions in malaria burden in many countries, scale up of targeted interventions to high-risk populations are critical to eliminate remaining parasite reservoirs in low-transmission settings. This study will apply novel genetic and social network analyses to survey data from malaria high-risk populations in Namibia to understand parasite and human connectivity and infer small scale malaria transmission patterns, intervention uptake, and potential impact of targeted intervention approaches. Results of this research will provide critical information whether targeted interventions in malaria high-risk populations hold promise for malaria elimination in this context and provide a template for tailoring interventions to optimize coverage and impact.